Identification of small molecule orexin agonists

ABSTRACT
The goal of this project is to identify novel small molecule orexin agonists via high-throughput screening (HTS)
of our in-house library of ~100k compounds. The orexin system consists of G protein-coupled receptors (GPCRs),
OX1R and OX2R, and their endogenous neuropeptides, orexin-A and B, and plays a critical role in multiple
functions including sleep and cognition. Orexin deficiency causes narcolepsy, a sleep disorder affecting 3 million
people worldwide, and is also found in aging, Alzheimer’s and Parkinson’s diseases, conditions with disrupted
sleep and cognitive impairment. Importantly, central administration of orexin-A reverses the narcoleptic
symptoms in animal models of narcolepsy. Similarly, our team found that ROXA-43 and ROXA-47, the first small
molecule dual orexin agonists developed by our team with low nanomolar potency and full efficacy at both OX1R
and OX2R, promotes wakefulness, reduces sleep, and enhances memory in mice, without producing conditioned
place preference (CPP). These findings support orexin agonism as a potential intervention for narcolepsy and
many other conditions with orexin deficiency. However, the neuropeptides orexin-A and B have been the primary
tools for orexin receptor activation, which are not suitable for systemic administration. Several small molecule
orexin agonists, which are mostly OX2R selective, have been recently disclosed, but no orexin agonist drugs
have advanced to the clinics. The most advanced candidate TAK-994 demonstrated statistically significant
improvement in daytime wakefulness in phase II clinical trials but has been discontinued for hepatotoxicity
concerns. The dual orexin agonists developed by our team have high molecular weight, poor brain permeability
and low solubility, highlighting the need for novel orexin agonists. In this application, we propose to identify novel
orexin agonists, particularly for OX2R, which plays a more prominent role in narcolepsy, by HTS of our in-house
compound library and to evaluate their biological activities and preliminary ADME properties. Discovery of orexin
agonists may provide basis for the development of orexin agonist-based pharmacotherapies for many
neurological disorders associated with orexin deficiency that currently do not have effective treatments.

Public health relevance
NARRATIVE Deficiency of the orexin neuropeptides causes narcolepsy and is also found in aging, early Alzheimer’s and Parkinson’s diseases. Administration of orexin peptides or other agonists reverses many of the symptoms; however, no small molecule orexin agonist drugs have entered the clinics. In this application, we propose to conduct high-throughput screening of our in-house compound library to identify novel small molecule orexin agonists.